Vanderbilt FIRST - Elevating Excellence and Transforming Institutional Culture

Scientific workforce diversity has been a longstanding challenge, and lack of progress negatively impacts
innovation, scientific discovery, and ultimately public health. Despite ongoing efforts, racial diversity among the
nation’s scientific research faculty remains low. Vanderbilt is well poised to build on this experience and achieve
more racial and ethnic diversity
among our scientific research faculty. The Vanderbilt Faculty Institutional
Recruitment for Sustainable Transformation Program (V-FIRST) will leverage substantial new institutional
commitments to diversity and inclusion, and will build on prior success, recruiting women faculty and Black and
Latinx postdoctoral fellows, to optimize recruitment and retention of Black, Latinx, American Indian, and Pacific
Islander faculty. With commitment of a 3:1 match of institutional dollars to NIH FIRST dollars, V-FIRST will
recruit at least 18 tenure-track faculty from minoritized racial and ethnic groups. With a leadership team
comprised of key institutional leaders who are highly committed to and experienced in recruiting, developing,
mentoring and sponsoring faculty from minoritized groups, we will achieve these goals:
Overall Aim 1: Identify and eliminate organizational barriers that impede full participation, advancement,
and thriving of racially diverse faculty in academia. We will implement sustainable and progressive
institutional policies that enhance diverse faculty hiring, retention, promotion, and tenure, and employ cross-
institutional strategies to cultivate inclusivity, cohesion, and belonging.
Overall Aim 2: In a series of three cluster hires, recruit 18-20 tenure-track, early-career scientific faculty
who are Black, Latinx, American Indian, and Pacific Islander, and establish a supportive and nurturing
environment for their success. Using an equity framework, we will implement an inclusive search process that
proactively identifies early career Black, Latinx, American Indian, and Pacific Islander scientists, equitably
evaluates applications, removes barriers to applying, and provides well-resourced start-up packages.
Overall Aim 3: Effectively mentor, retain, and support diverse early-career scientific faculty to promotion
with tenure. In addition to Vanderbilt’s vast faculty development resources, we will provide V-FIRST faculty with
a multi-tier mentoring and nationally recognized senior scientists as sponsors. We will reduce isolation and
increase sense of community with social and culturally-relevant activities that enable V-FIRST faculty to thrive.
Overall Aim 4: Comprehensively evaluate V-FIRST’s hiring process, career development activities and
the impact of V-FIRST on Vanderbilt’s culture. Using an equity lens, we will determine the effectiveness of
the V-FIRST program through process and outcome indicators that measure change at multiple levels, including
faculty development, mentoring and relationships, and institutional policies, practices, and culture. We will use
data collected through evaluation to inform ongoing program improvement and institutional change.

Public health relevance
PROJECT NARRATIVE Vanderbilt FIRST will build on prior success and implement novel, equitable and inclusive strategies to recruit, retain, mentor and promote early-career scientific faculty from racial groups historically excluded from science. Ultimately, efforts will lead to sustainable transformation and an institutional culture of inclusive excellence.